Transdisciplinary Research Training to Reduce Disparities in Preterm Birth and Improve Maternal and Neonatal Outcomes

PROJECT SUMMARY
Fifteen million babies are born preterm each year, of whom one million die within their first 28 days of life,
making preterm birth the leading cause of death in neonates, infants and children under age 5. Moreover,
premature infants who do survive often have lifelong physical disability and cognitive impairment. In the US,
Black women are 1.5 times more likely to deliver preterm than women from other racial/ethnic groups.
Nonetheless, despite years of research, little progress has been made in reducing preterm birth rates, and
disparities are increasing. In view of these critical public health issues, the Pregnancy and Perinatology Branch
at NICHD has included preterm birth and its consequences, perinatal health disparities, global perinatal health
and elimination of neonatal pain among its 7 priority topics. The overarching goal of “Transdisciplinary
Research Training to Reduce Disparities in Preterm Birth and Improve Maternal and Neonatal Outcomes” is to
train a cadre of investigators from a wide range of clinical specialties, scientific disciplines, and lived
experiences who will be poised to engage in rigorous, transdisciplinary, collaborative efforts to 1) identify and
elucidate the mechanisms by which biomedical, psychosocial, interpersonal and institutional factors increase
the risk for preterm birth and associated adverse outcomes for infants, mothers, and families locally and
globally; 2) develop, test and implement interventions to reduce the rate of preterm birth and associated
adverse outcomes; and 3) eliminate disparities in preterm birth and adverse outcomes in this country.
In 2014, with funding from the Bill & Melinda Gates Foundation and Marc and Lynne Benioff, UCSF
established the Preterm Birth Initiative, an innovative, health-equity focused, transdisciplinary research
program that takes a cell-to-society and life course approach to reduce the local and global burden of preterm
birth. As part of that initiative, a pilot postdoctoral fellowship program was launched to train the next generation
of scholars to tackle the vexing preterm birth epidemic in the US and globally. Nine fellows representing varied
clinical specialties (obstetrics, neonatology, pediatric neurology and midwifery) and scientific disciplines
(biology, anatomy, public health, psychology, sociology and epidemiology) have enrolled, and all of the
graduates have gone on to faculty positions, primarily with funding from NIH K-level awards.
The specific aim for this proposal is to build on the success of the pilot fellowship program and ensure its
sustainability. We will recruit 12 postdoctoral fellows (3 per year for 4 years, with a balance of MDs and PhDs)
and provide them with the resources and mentorship they need to develop into independently funded scientists
working collaboratively to change the course on preterm birth. Fellows will work with mentorship teams to
design and implement research projects and engage in weekly didactic activities to further their skills and
experience in conducting transdisciplinary research. Program components will also include advanced courses
in research methods and ethics, seminars and grand rounds, peer review activities, and paper/grant writing.

Public health relevance
PROJECT NARRATIVE The long-term goal of “Transdisciplinary Research Training to Reduce Disparities in Preterm Birth and Improve Maternal and Neonatal Outcomes” is to train the next generation of scientists to 1) determine the causes and mechanisms of preterm birth in the US and globally; 2) develop, test, and implement interventions to reduce the rate of preterm birth and improve outcomes for babies born preterm and their families; and 3) eliminate disparities in rates of and outcomes from preterm birth. The short-term goal is to build on the major successes of a pilot fellowship program we launched with funding from philanthropic organizations by both ensuring its sustainability and expanding the program further. We will recruit 12 postdoctoral fellows (3 per year for 4 years, with a balance of MDs and PhDs), and use T32 funding to provide them with the resources and mentorship they need to develop into independently funded scientists working collaboratively to bend the curve on preterm birth.